Enrichment Core

Project Summary: The Enrichment Program of Yale’s U54 Cooperative Hematology Specialized Core
Center application seeks to enhance scientific knowledge exchange and learning opportunities among
trainees, researchers, and clinicians involved in, or wishing to become involved in, NIDDK hematology
research relevant areas. The Enrichment Program will supplement the rich infrastructure of existing resources
at Yale in basic, translational, and clinical hematology research including the Yale Stem Cell Center, the Yale
Center for Clinical Investigation, the REDS-IV-P Trainee Program, and multiple Yale-subsidized Research
Cores. Through inspired mentoring, the proposed Enrichment Program will also build upon existing NIH
funded, internally funded, and externally funded programs to train the next generation of hematology
researchers. Directed by physician scientists, this Enrichment Program has the following specific aims: 1) To
promote scientific exchange between investigators in NIDDK hematology research relevant areas, including
hematology and non-hematology researchers (both MD and MD/PhDs as well as PhDs), internal and external
investigators, trainees and clinicians; 2) To broaden hematology research opportunities for trainees. Initiatives
proposed to be financially supported through this Enrichment Program include a quarterly Distinguished
Hematology Seminar Series, a ‘Leaders in Science’ course for post-doctoral fellows (from Yale and other
CCEH sites), a Summer Enrichment Research Program for Underrepresented Minority Undergraduate
Students from local colleges in New Haven, and a research exchange program for trainees from other CCEH
sites. Though the budget for this Enrichment Program is not large, the anticipated return on investment
(including the impact of the proposed seminars, inspired mentoring, and training opportunities for young
hematology researchers) will be long lasting. The long-term goal of this Enrichment Program, relevant to public
health, includes strengthening the ‘bench to bedside and back’ hematology discovery model. Taken in
combination, the proposed U54 Cores and Programs will have a sustained, powerful influence on the future of
hematology research and, ultimately, on patient care.